Partnering with Antenatal Navigators to Transform Health in Pregnancy (PATH)

PROJECT SUMMARY
In the US, pervasive and insidious disparities in maternal health are urgent public health concerns. Social
determinants of health (SDoH), such as poverty, exposure to racism, and limited access to care, critically shape
perinatal outcomes, resulting in greater risk of adverse maternal and neonatal health outcomes for low-income
and minority individuals. High-quality antenatal care supports optimal health, yet typically fails to meet the needs
of marginalized populations. Improving the health of pregnant people in a patient-centered, equity-focused
manner requires innovative models of care delivery across the spectrum of maternal care. One strategy
is patient navigation (PN), a longitudinal, barrier-focused, patient-centered intervention that offers support for
health services. Although antenatal care is an ideal setting for PN, the benefits of antenatal PN for overall
maternal and perinatal health have not been rigorously evaluated in randomized trials.
This proposal aims to test the efficacy of an innovative antenatal care PN model that extends and expands care
for low-income pregnant individuals via the Partnering with Antenatal Navigators to Transform Health in
Pregnancy (PATH) Trial. We will randomize 550 racially and ethnically diverse, nulliparous pregnant individuals
with low income (publicly funded antenatal care or income <200% of federal poverty line) to receive PN via PATH
versus usual antenatal care. Participants randomized to receive PATH will receive intensive, individualized PN
services throughout pregnancy. As a multilevel, multidomain, health equity-focused intervention, PATH is
grounded in understanding and addressing SDoH to promote self-efficacy, enhance access, support
communication, and sustain healthcare engagement. All participants will undergo surveys, interviews, and
medical record reviews at 5 study visits from enrollment (<20 weeks of gestation) through 9 months postpartum.
Aim 1 will evaluate whether PATH, compared to usual care, improves a composite of maternal adverse outcomes
(hypertensive disorders, preterm birth, postpartum hemorrhage, severe maternal morbidity, mortality) and (Sub-
Aim 1) healthcare utilization. Aim 2 will evaluate whether PATH, compared to usual care, improves a composite
of perinatal adverse outcomes (NICU, low birthweight, small- and large-for-gestational age, perinatal death) and
(Sub-Aim 2) healthcare utilization. Exploratory Aims 1 and 2 will evaluate whether PATH’s efficacy varies by age,
self-reported race/ethnicity, or chronic disease status. Aim 3 will evaluate patient, clinician, navigator, and health
system experiences with PATH, which will be guided by implementation science principles and accomplished
via serial collection of patient-reported outcomes, individual interviews, and process mapping exercises. The
PATH Trial will fill a significant evidence gap by demonstrating whether antenatal PN among low-income
pregnant individuals, who are disproportionately at risk for adverse outcomes, is an effective strategy
to improve perinatal health and reduce disparities. PATH represents a critical step in understanding how to
improve maternal health for disadvantaged individuals, thus achieving the goals of the NIH IMPROVE Initiative.

Public health relevance
PROJECT NARRATIVE Antenatal care commonly fails to meet the needs of low-income pregnant individuals, who are at increased risk for adverse pregnancy outcomes due to effects of racism, poverty, and inadequate attention to social determinants of health. Addressing the pervasive disparities in maternal and neonatal health requires innovative, sustainable, and more effective models of antenatal care delivery; one strategy may be patient navigation, a barrier-focused, longitudinal, patient-centered intervention that offers support for a defined set of health services. The Partnering with Antenatal Navigators to Transform Health in Pregnancy (PATH) proposal to evaluate a novel, comprehensive antenatal patient navigation program among low-income pregnant people has the potential to meaningfully improve maternal and neonatal health and reduce disparities in maternal morbidity and mortality.